Information Dissemination Core

Project Summary / Abstract
The Information Dissemination Core CD001 proposes three interrelated specific aims designed to advance
NIAAA's mission of translating and disseminating research findings to health care providers, researchers,
policymakers and the public. All of the Core's activities are targeted especially to under-represented minorities
and/or other disadvantaged groups. Specific Aim 1: K-12 Education & Outreach. The principal goal is to
provide K-12th grade students and their teachers with information about alcohol, the brain, and neuroscience.
We propose age-appropriate activities that present information about how the brain works and how alcohol can
affect it. The activities promote keeping one's brain safe, making informed choices, meeting male and female
neuroscientist role models from diverse backgrounds, and pursuing careers in neuroscience and alcohol
research in particular. Aim 1 focuses especially on adolescent vulnerability to alcohol abuse by utilizing
material from the NIAAA curriculum, Understanding Alcohol: Investigations into Biology and Behavior, and from
other sources. New for the renewal, we propose to prepare high school students to make presentations in their
school's respective feeder middle schools. We will initially partner with Portland Public School's Benson
Polytechnic High School health careers program in order to bring more diverse and disadvantaged students
into health science research and clinical practice. The high school students will discuss with their middle school
near-peers the changing adolescent brain and how to transition successfully to high school. We propose to
continue a novel neuroscience and safety curriculum developed by this Core for Kindergarten-3rd graders, with
more advanced activities to be added for 4th and 5th graders. At the high school level we continue a Genetics
and Alcohol seminar that is adaptable from lab visits to in-school classroom visits to auditorium talks, and an
interactive sports team seminar focusing on the effects of alcohol on athletic training, performance, and
recovery. A new 3-module curriculum on biological responses to alcohol is proposed for high school health
professions students. Specific Aim 2: Training in Alcohol Research. Here, we propose to provide training
and laboratory experience in alcohol research to high school, undergraduate, graduate, and post-doctoral
students. Training the next generations of alcohol researchers has been a major commitment of many PARC
investigators, some for over 30 years. Specific Aim 3: Dissemination and Translational Interface. In this
Aim we propose to coordinate and share the findings of the Center, and alcohol research results in general,
through a variety of well-established mechanisms with scientific colleagues, policymakers, and diverse
communities. Aim 3 proposes activities and resources including: professional and lay publications; the Center
website for professionals and the general public; the PARC Library; inclusion of PARC investigators in the
University's speakers and scientific experts bureau; dissemination of PARC findings to the media; professional
conferences; and outcome review of the education and outreach activities of the Core.